Development of a Novel Inhibitor of Ricin: A Potential Therapeutic Lead against Deadly Shiga and Related Toxins

Abstract The PI proposes a high-impact collaborative research project to develop new inhibitors for ribosome inactivating proteins (RIPs), such as ricin and Shiga toxin. Ricin toxin, produced by the castor bean plant, has a nefarious past. Ricin is a well-known homicidal poison and has been used in several bioterrorist attacks. Shiga toxin is a deadly product of enterobacterial Escherichia coli. RIPs are RNA N-glycosidases that enzymatically remove specific purine residues from the universally conserved sarcin/ricin loop (S/R loop) of large ribosomal RNA, causing cellular death. There are no effective pharmaceuticals for either ricin or Shiga toxin poisoning. The PI proposes using a viral protein (VPg) from turnip mosaic virus that we have shown to inhibit ricin activity in vitro. The goals of this proposal are: 1) Establish conditions for VPg-ricin complex formation and the rates of VPg-ricin interactions; 2) Determine minimum VPg peptide that effectively inhibits ricin and Shiga toxins; and 3) Optimize conditions to enhance inhibition of these toxic proteins. This is an innovative activity. Based on the structural and mechanistic similarities of these toxins and previously acquired data showing that VPg peptides inhibit ricin activity in vitro, we believe the outcomes of this activity will provide leads for the synthesis of therapeutic peptides. In turn, this will serve as a catalyst for the development of constructively applied solutions for the inhibition of these deadly toxins. Furthermore, this proposal will enhance the infrastructure of research and education at John Jay College, introducing biochemical and biomedical research experiences to underrepresented minority and female students, who would otherwise lack such opportunities. This would allow them to experience a broad spectrum of techniques, and acquire skills such as data analysis used in modern scientific investigations, while developing a vast network of partnerships among scientists from national and international institutions.

Public health relevance
Public Health Relevance Statement Ricin and related Shiga toxins are potentially lethal poisons, which as of yet, have no effective pharmaceutical treatments or preventions. The global problem of these poisons is an increasing threat to public health, directly relating to the mission of the National Institutes of Allergy and Infectious Diseases. Ricin, astoundingly easily acquired, is an ideal toxin for bioterrorism, while the widespread transmission of E. coli poisoning is responsible for many severe human illnesses and several fatalities. In the future, it may be possible to utilize these toxins for their public health benefit, by repurposing them to attack specific human and animal diseases.